Novel Strategies to Treat Diffuse Midline Glioma with CAR T Cell Therapy

PROJECT SUMMARY
Although chimeric antigen receptor (CAR) T cells have been remarkably successful in the hematologic setting,
identification of truly tumor specific antigens for many solid tumor indications has limited broad translation. Two
targets have been considered for Diffuse Midline Glioma H3 K27M-mutant tumors (previously Diffuse Intrinsic
Pontine Glioma (DIPG)), however as neither are exclusively restricted to neoplastic tissue, safety concerns
exist with respect to on-target, off-tumor toxicity. Moreover, ancillary treatment meant to boost CAR T function
to overcome a constellation of immune suppressive mechanisms associated with the solid tumor
microenvironment also has the potential to exacerbate the problem. Our group has conducted extensive
preclinical characterization of oncolytic viruses and has demonstrated them to be a highly effective
immunotherapeutic agents for the treatment of cancer. We propose to leverage the tumor tropism of ∆24
oncolytic adenovirus to deliver a CAR target along with CD40L. Our preliminary data indicates that oncolytic
Ad∆24-CD40L provides a significant therapeutic advantage in a GL261 glioma model as a monotherapy, and
further, can potentiate CD19 CAR T therapy in a proof of concept combination setting against subcutaneous
B16-CD19 tumors. The goal of this proposal is to develop a dual therapy approach which builds on direct
tumor cell viral oncolysis and CAR T cytolysis, enhanced CAR T cell recruitment/activation by virus-mediated
inflammation, and importantly, CD40L-mediated mobilization of endogenous antigen presenting cells, B cells
and T cells. We will engineer an oncolytic vector to deliver titratable levels of CD40L using the E. coli DHFR
destabilizing domain, and an intracellularly truncated signaling-dead EGFRvIII molecule to be used in
conjunction with safety tested EGFRvIII CAR T cells (Aim1). The safety and efficacy of the OV-CAR T
approach will be evaluated in a genetically engineered immunocompetent model of DIPG (Aim 2). This project
is expected to provide novel insight into how CD40L can mobilize an endogenous B cell and T cell response
and support CAR T therapy. Together, we hope to capitalize on the properties of designer oncolytic viruses to
more broadly enable the use of CAR T cell therapy in solid tumors, and in particular apply existing safety
tested immunotherapies to a devastating and urgent unmet clinical need.

Public health relevance
PROJECT NARRATIVE Diffuse Midline Gliomas manifest as an aggressive disease that represent a devastating and urgent unmet clinical need. This research project will explore a combinatorial approach wherein Chimeric Antigen Receptor (CAR) modified T cells are targeted to tumor cells by an accessory oncolytic virus expressing both a CAR antigen (EGFRvIII) and an immune stimulant (CD40L). We reason that this technology will (1) enable rapid translation of existing safety-tested immunotherapeutics to a disease for which no truly tumor specific antigens exist and (2) mobilize the patient’s own immune system to provide long lasting protection.